CDX GENE FUNCTION IN CARDIOMYOGENIC DIVERSIFICATION

RESEARCH PROPOSAL: Scientific Merit: The merit of the larger question being asked, what are the molecular mechanisms which generate anteroposterior plasticity in the heart, is high. The three specific aims are put forth in a logical manner and represent a nice mix of descriptive and mechanistic approaches. The loss and gain of function studies described are state-of-the-art and should provide proof of function for the homeoproteins under study. The third specific aim is less rigorous and strangely incomplete in that only the CdxA, B, C transcripts will be monitored. The lack of any mechanistic facet of the aim, such as an identification of downstream targets and testing their function, is somewhat disappointing but may not have been proposed considering the time constraints of the award. Overall, the scientific merit of the proposal is excellent.